Novel Mechanistic Approaches in Prevention, Treatment and Non-Invasive Assessment of Radiation Cystitis in Mice

ABSTRACT
Pelvic organ tumors in men and women are projected to account for 40% and 18%, respectively, of new cancers
diagnosed, and 31% and 26%, respectively, of cancer related deaths in the United States in 2020, according to
the American Cancer Society’s Cancer Facts & Figures 2020. While nearly half of all pelvic cancer patients
receive radiation therapy, the dose is limited and fractionated over weeks due to the potential for developing
radiation cystitis. This is a debilitating secondary condition that can lead to disruption of the urothelium,
inflammation, neurogenic detrusor overactivity (NDO), hemorrhagic cystitis and chronic fibrosis that may require
a cystectomy. Current therapies such as cystoscopic fulguration, intravesical formalin and hyperbaric oxygen
are often ineffective and focus on restricting hemorrhage rather than urological consequences. Thus, there is a
critical need for preclinical models to better understand the pathophysiology of radiation cystitis, design novel
mechanistic approaches in its prevention and treatment and non-invasive monitoring of these outcomes using
clinically viable imaging methods. In our mouse models, bladders are either externalized or instilled with an
infrared dye for selective irradiation (10Gy; 1Gy=100rad) to cause radiation cystitis with an acute phase (1-
3days) characterized by urothelial cell (UC) apoptosis and disruption of barrier function, and a chronic phase
(8wks) with inflammation, afferent sensitization, NDO, and eventually collagen deposition, fibrosis and
decreased bladder wall compliance. We propose to test mechanistically different classes of therapeutic and
contrast agents for which we have strong preliminary data: 1) Mitochondrial targeted free radical scavenger,
XJB-5-131, to decrease reactive oxygen species that inhibit mitophagy; 2) p75 neurotrophin receptor (p75NTR)
modulator, LM11A-31, to decrease urothelial cell apoptosis and barrier disruption; 3) soluble guanylyl cyclase
(sGC) activator, cinaciguat, to decrease inflammation, afferent sensitization and collagen deposition to treat NDO
and fibrosis; and 4) intravesical infrared dye and novel contrast media mixture, gadobutrol/ferumoxytol, to
selectively irradiate the bladder within the abdomen and to enhance the capabilities of magnetic resonance
imaging (MRI) for non-invasive assessment of fibrosis in the bladder wall, respectively. As LM11A-31 and
cinaciguat have passed phase 1 clinical safety trials for non-urological pathologies, they have considerable
clinical relevance in the prevention and treatment of radiation cystitis. The overall goals of the proposal are to
better characterize the pathophysiology of radiation cystitis and to design clinically relevant treatment protocols
utilizing the proposed agents individually or in combination. Progress toward this goal will be monitored using
decerebrate or awake (telemetric) cystometrogram (CMG) recordings, MRI, histological and molecular
approaches, mitophagy reporter (mt-keima) mice, and conditional knockout mice for NADPH cytochrome b5
reductase 3 (CyB5R3) in smooth muscle or nerves which renders sGC unresponsive to NO• in these cells.

Public health relevance
NARRATIVE Radiation cystitis is a debilitating condition caused by pelvic tumor irradiation that is associated with inflammation, neurogenic detrusor overactivity, hemorrhagic cystitis and chronic fibrosis that may require a cystectomy and where current therapies, which are often ineffective, focusing only on controlling hemorrhaging. Accordingly, our goals are to better characterize the pathophysiology of radiation cystitis in order to implement novel agents, to be used singly or in combination, to enhance its treatment: 1) mitochondrially targeted free radical scavenger, XJB-5-131; 2) p75 neurotrophin receptor (p75NTR) modulator, LM11A-31; 3) soluble guanylyl cyclase (sGC) activator, cinaciguat; and 4) intravesical infrared dye or contrast media mixture, gadobutrol/ferumoxytol, to selectively irradiate the bladder within the abdomen, or enhance non-invasive magnetic resonance imaging (MRI) of bladder wall fibrosis, respectively. As LM11A-31 and cinaciguat have passed clinical safety trials for non-urological pathologies, the proposal has considerable clinical relevance.